Impact of breastmilk on Campylobacter jejuni survival

PROJECT SUMMARY
Campylobacter jejuni is a major cause of bacterial-induced diarrhea worldwide. Infection leads to high rates of
morbidity and mortality in low-and-middle income countries (LMICs), particularly in young children where up to
85% of infants are C. jejuni stool positive by one year of age. Also, post-infectious complications such as Guillain-
Barré syndrome, irritable bowel syndrome, reactive arthritis, and environmental enteric dysfunction (EED) are
increasingly reported. EED is a subclinical chronic disorder resulting from improper nutrient absorption, intestinal
injury and prolonged inflammation that leads to growth stunting, impaired cognitive development, and further
complications. In parallel, campylobacters continue to show increasing rates of fluoroquinolone resistance,
particularly ciprofloxacin, and are thus high priority pathogens for new antimicrobial development.
Through genomics studies examining Campylobacter infection profiles in seven sites in sub-Saharan African
and South Asia, we discovered that exclusively breastfed infants showed a significantly higher abundance of C.
jejuni in their stools compared to non-breastfed infants, and that breastfed infants were predominantly colonized
with asaccharolytic (non-carbohydrate metabolizing) strains of C. jejuni while infection with fucose-metabolizing
campylobacters was less frequent. While examining the mechanism behind this selection, we discovered that
human breastmilk is unexpectedly toxic to C. jejuni. This finding was confirmed using 5 different isolates and 5
independent breastmilk donor samples. Through directed evolution studies, we isolated C. jejuni strains resistant
to breastmilk and demonstrated that the milk bioactive agents were derived from proteins and lipids. This study
will investigate how components of human breastmilk can suppress the survival of C. jejuni, and in turn
will explore how C. jejuni can develop resistance to those components.
The specific aims of this project are to identify the bactericidal lipids and antimicrobial peptides within a pooled
collection of human breastmilk, then characterize the mechanisms by which C. jejuni can become resistant to
these components, and subsequently test how the identified C. jejuni mutations and toxic milk components
impact bacterial colonization in a mouse model of C. jejuni-induced EED.
Completion of these aims will fill major gaps in our understanding of EED development and how breastmilk
components influence C. jejuni colonization. This study may also identify novel treatments to prevent colonization
with this pathogen to reduce the burden of disease and mortality.

Public health relevance
NARRATIVE Bacteria such as Campylobacter jejuni cause severe cases of diarrhea and growth-stunting worldwide. C. jejuni infections are particularly common in breastfed infants in low-and-middle income countries, yet we recently discovered that human breastmilk is toxic to C. jejuni. This proposal will identify the toxic components in milk, examine the mechanisms by which C. jejuni can develop resistance to milk, and study how these resistance traits and milk antimicrobials impact bacterial survival in a mouse model of C. jejuni-induced growth-stunting.